Improving the effectiveness of anti-tuberculosis drugs by developing a point-of-care therapeutic drug monitoring system for areas with limited medical resources

Project Summary / Abstract
Every year, roughly 10 million people are diagnosed with tuberculosis (TB) and it is responsible for over 1.5
million deaths annually. Currently, TB is treated with a four-drug regimen over a period of 6 – 9 months and it
has cured ~ 85% of the infected people. With good facilities and support, RIPE regimen can cure up to 98% TB
cases. However, if there are no sufficient resources to monitor the treatment, success rate can quickly drop to
65% and unfortunately, most of the new TB cases are identified in developing countries with limited medical
resources. Treatment failure can lead to drug resistance, which is harder, more expensive and takes much longer
time to treat. To avoid treatment failure, it is crucial to ensure an individual receive enough drug exposure (drug
level in blood) from the pills he or she ingested, especially for people co-infected with HIV or with diabetes, since
these conditions can greatly alter the drug exposure. Furthermore, due to the natural properties of these drugs,
significant blood level variation can be observed based in individual’s physical, dietary and clinical status.
In areas with sufficient medical resources, blood concentration of anti-TB drugs can be measured via
therapeutic drug monitoring (TDM) to assess drug exposure. However, current TDM methods rely solely on time
consuming laboratory analyses using instrument that requires substantial cost and trained personnel, which are
not practical on a large scale in nations trying to eradicate TB. As a result, we proposed to develop a TDM
platform for anti-drugs that is more suitable for these areas. In the Phase I project, we are going to demonstrate
the feasibility of such TDM platform by first developing a test for rifampicin, an anti-TB drug used through the
treatment that would benefit from close monitoring due to its wide variation between individuals. The proposed
rifampicin test is based on the existing blood glucose meter (BGM) hardware and a disposable cartridge to allow
affordable testing with accuracy, convenient operation and short testing time at the point-of-care. As the
culmination of decades of R&D, today’s BGM is designed for small footprint, simple operation, affordability and
large-scale production. Leveraging the BGM technology with a familiar assay format for uses allows us to reduce
the risks and costs associated with device development and scale-up production. The final product we envision
will be a completed system that can perform TDM tests for all first-line drugs while requiring only minimal cost
and training to operate. Such system, in conjugation with better treatment program oversight may provide the
foundation for reducing the overall TB burden.

Public health relevance
Project Narrative Tuberculosis represents a significant healthcare burden especially for developing countries and today’s anti- TB treatment can effectively cure TB if it is monitored properly. Unfortunately, for countries with most of the TB burden, they do not have the resources to reach the maximum effectiveness the current anti-TB drugs can offer, including the ability to assess the drug exposure by monitoring their blood levels. For this Phase I project, we are going to demonstrate the feasibility of an anti-drug level monitoring system that is affordable and convenient to use by using existing blood glucose meter platform.